A seek, test, and treat intervention to reduce Chlamydia trachomatis disparities in youth living in the deep South

Chlamydia trachomatis (Ct) is the most common reportable sexually transmitted infection in the United States that causes severe and costly morbidity. Youth are highly impacted, particularly those in the Deep South. In over two decades of Ct screening in young women, population-based rates of Ct have declined for some youth but not others, and clinic-based Ct screening is accessed less frequently than recommended by women, indicating that a different approach is needed. We posit that a community-based, seek, test, and treat approach is required. Check It (NICHD/NIAID R01HD086794) was a seek, test, and treat bundled network approach to reducing chlamydia rates in youth that was designed for young men. In 33.5 months of recruitment, we screened 1907 men and found a 10.6% Ct positivity rate. We found that screening men reduced the rate in women by an average of 2.1 percentage points compared to synthetic control sites; for every 5 men screened, 1 infection in women was averted; and that the program costs were $5,468 per QALY gained. The study goal is to further adapt and refine Check It, a seek, test, and treat community-based Ct prevention program aimed to reduce Ct rates among youth in the United States. We will achieve this in three aims: Aim 1. To adapt and refine Check It – Using the ADAPT-ITT framework and in collaboration with our intended population, content experts, and community partners, we will make five adaptations to the program: inclusion of both sexes, use of doxycycline, addition of a home collection option, refinement of incentivized peer referral, and extragenital self-collection in the first year and then readapt as needed in the third year. We will conduct interrupted time series analysis & hypothesize that these adaptations will increase enrollment. Aim 2. To determine efficacy and cost-effectiveness of the adapted Check it– After adaptations and implementation among youth in New Orleans (N=2322), using Medicaid data, we will compare New Orleans (intervention) to synthetic controls to examine the adapted program’s impact on women’s Ct rates. We will also use time-motion analysis to examine the cost-effectiveness, hypothesizing that inclusion of both men and women is cost effective and will logarithmically reduce the rates of Ct infection in women. Aim 3. To examine the feasibility/utility of Ct/GC extragenital and syphilis/HIV testing – Participants will be offered extragenital specimen self-collection & syphilis/HIV testing. We hypothesize that >80% will accept to do extragenital testing and that syphilis/HIV rates will exceed the national average. To break down health issues, it is essential to go to the communities of those impacted. If successful, Check It II can serve as a model for other sites ultimately reducing Ct differences on a broader basis. Check It II could also serve as a model for other STI interventions in this population such as doxy PrEP or vaccines.

Public health relevance
Chlamydia trachomatis (Ct) is a common treatable sexually transmitted infection that can result in important morbidity and, despite decades of clinic-based screening, cases continue to increase, especially in the South. Check It is a community-based, bundled, seek-test-and-treat Ct intervention originally designed for men who have vaginal sex and was impactful in reducing Ct rates among women. To expand its potential impact, we will examine the feasibility/acceptability of inclusion of both sexes, provide data for possible changes in treatment guidelines, examine acceptability of home specimen collection, examine the effect of incentivized peer referral, examine the utility of HIV/syphilis testing, and feasibility of extra-genital self-collected swabs, as well as program efficacy and cost-effectiveness.